The landscape of HLA mediated variation in health and immunity

Project Summary
The Human Leukocyte Antigen (HLA) region on human chromosome 6p21 is the most medically important region of the
human genome. More than 100 infectious, autoimmune and pharmacological disease phenotypes and cancers are associated
with genetic variation of HLA. Nevertheless, despite nearly a half-century of study investigating HLA and disease
association, outstanding questions remain regarding the full extent of HLA mediated impact on human health and disease.
A major limitation to these studies, lack of sufficient sample size for discovery and replication, can be attributed to the
complex nature of the HLA region such that it is often impractical to undertake association studies in very large cohorts. To
date, nearly all large-scale studies examining HLA variation in human health have relied on statistical imputation of HLA
alleles from SNP (single nucleotide polymorphism) data, rather than direct genotyping of these loci. Here, we propose to
exploit pre-existing, high-quality HLA genotyping data collected by the National Marrow Donor Program in order to
examine the impact of HLA variation in human health and immunity at unprecedented scale. We will collect self-reported
health histories from a sample of greater than 100,000 individuals, allowing examination of genotype-phenotype
associations with high-resolution genotypes. Further, we will examine the relationship between HLA variation and antibody
response to human cytomegalovirus (CMV) in more than 1,000,000 individuals. To provide context to the association
studies, we will examine the relationship between HLA variation and antigenic targets of antibodies in more than 1000
healthy individuals. In Specific Aim 1 we will build a very large dataset collected through the National Marrow Donor
Program (NMDP) to identify potential HLA associations across numerous diseases and phenotypes in a Phenome Wide
Association study (PheWAS). Phenotype information for PheWAS analysis will be obtained from self-report survey data
for approximately 130 conditions, diseases and traits from subjects with HLA genotyping collected by NMDP. In Specific
Aim 2 we will determine the antigen specificity of antibodies in serum samples from healthy subjects, stratified by HLA
genotype. We will utilize a programmable phage display assay, comprised of 744,000 peptides tiled across the human
proteome, representing the entire human peptidome. Additionally, we will screen against the phage display for the virome
(480,000 peptides) for specificity for viral antigens, and test binding of these antigens to HLA molecules. We will examine
serum samples from over 1000 healthy donors. In Specific Aim 3, we will specifically address serostatus with respect to
human cytomegalovirus (CMV) in a sample of over a million individuals. CMV is ubiquitous in all human populations and
infection can have profound effects on the immune system. This analysis will provide the first large-scale examination of
the association of HLA variation with CMV serostatus. Across multiple elements of human health and immunity, the key
feature of this study is the extraordinarily large sample size projected for each of our aims, made possible through our
leveraging of existing high-resolution HLA genotyping data. In doing so, we will extend our understanding of the effect of
these important immune loci in human health across a wide range of conditions, across multiple ancestries reflective of the
United States population.

Public health relevance
Narrative The overall goal of this project is to establish and refine the association of genetic polymorphism of the human leukocyte antigen (HLA) complex with a wide variety of health traits and immune markers in a cohort of unprecedented size. Central to immunity and critically important for human health, HLA molecules are encoded by complex genetic systems with extraordinarily high levels of sequence and structural variation and complex expression patterns that has been linked to hundreds of diseases. We will leverage the wealth of existing genetic data collected by the National Marrow Donor Program (NMDP) to examine these associations in fine detail in hundreds of thousands of individuals in order to improve our understanding of the role of HLA in human health and immunity.